GENE REARRANGEMENTS AS TUMOR SPECIFIC MARKERS

Structural alterations and expression of immunoglobulin (Ig), T-cell receptor (TCR) and various growth affecting genes are studies in normal, "premalignant," and malignant tumors and cell lines. A. We have shown that hybrid genes are formed by site specific recombination between variable segments from one immune receptor locus and joining segments from another. We have demonstrated that such events occur in the peripheral T-cells of all normal individuals but are 100 times more frequent in the peripheral T-cells of patients with ataxia-telangiectasia (AI). These hybrid genes 1) affect and alter the repertoire of immune receptor diversity, 2) suggest that an underlying defect in AT may be chromatin "hyperaccessibility," and 3) provide a possible screening test for people at an increased risk for the development of lymphoid specific chromosomal translocations, and therefore lymphoid malignancy. We have recently completed a pilot study of individuals involved in the agriculture industry in which we have demonstrated an acquired transient "AT-like" picture in individuals exposed to a variety of pesticides and herbicides. These individuals are the same population for which epidemiological studies have suggested an increased risk of leukemia and lymphoma. B. We have identified a gene, SCL, involved in a nodal point in hematopoietic development. In collaboration with the Children's Cancer Study Group (CCSG) and the Southwest Oncology Group (SWOG) we have used the SCL probe in tumor genotyping studies on patients with lymphoid disorders and found SCL disruption to occur in 20-30% of childhood T-cell ALL pronounced SCL expression in M7 AML and CD34+ CML blast crisis. Gene and transcript mapping. We have localized numerous genes of interest to specific regions of human chromosomes. Most recently using biotinylated probes we have mapped one putative neurogenic gene NSCL-1 to human chromosome lq2l and a second, NSCL-2, to human chromosome lql2. Furthermore, we are using RNA tissue in situ hybridization as a means of detecting transcripts of interest in individual cells. We are also engaged in a protocol to assess the utility of an SCL based PCR assay to determine and follow minimal residual disease in a subset of CCSG patients.